Mobile Video interpretation to Optimize Communication Across Language barriers: mVOCAL

Project Summary
Over 25 million people in the United States (US) have limited English proficiency (LEP). LEP populations
face substantial barriers to high-quality healthcare, resulting in disparate outcomes such as elevated risk for
serious safety events, increased costs, and decreased comprehension, satisfaction, and adherence.
Professional interpretation is an evidence-based practice to improve care and mitigate these disparities.
However, its use remains persistently low despite legal and regulatory mandates. Previous strategies to
improve use have mainly addressed intrapersonal barriers (provider knowledge and skills, via in -person
education) or the system (simplifying telephone interpreter access). Educational strategies have improved
provider knowledge with unknown effect on interpreter use; systems strategies have achieved modest
improvements in use. However, these strategies have lacked clearly articulated mechanisms or causal
pathways, often as part of expensive, multifaceted interventions that limit precise attribution and scalability.
In this study, the investigators will compare two discrete implementation strategies for improving
interpreter use, the first an enhanced education strategy targeting primarily intrapersonal barriers but delivered
in a scalable format (interactive web-based educational modules), and the second targeting system barriers,
with a novel focus on mobile video interpretation (mVI), accessible on providers’ own mobile devices. The
study’s specific aims are: (1) Compare the effectiveness of two implementation strategies, alone and in
combination, to improve use of interpretation and comprehension for LEP patients/parents seen in
adult/pediatric primary care settings; (2) Explore mVI and education implementation strategies’ ability to
activate putative provider-level mechanisms; and (3) Determine the incremental cost effectiveness from a
healthcare organization perspective of each implementation strategy (mVI, education, both). To accomplish
these aims, the investigators will conduct a Type III hybrid implementation-effectiveness study in 6 primary
care clinics, using a Sequential Multiple Assignment Randomized Trial (SMART) design . Enrolled providers
(total n=50) will be randomized to mVI or educational modules, in addition to standard interpreter access. After
9 months, providers with high interpreter use will continue as assigned; those with lower use will be
randomized to continue as before or add the alternative implementation strategy. Providers will complete
surveys and in-depth interviews to understand barriers to interpreter use, based on the Theoretical Domains
Framework. LEP patients will be surveyed (n=648) and interviewed (n=75) following visits with enrolled
providers to understand their experiences with communication and interpretation. Determining how these two
scalable strategies, alone and in sequence, perform for improving interpreter use, how they do so, and at what
cost, will provide critical insights for addressing a persistent cause of healthcare disparities.

Public health relevance
Project Narrative Patients and families with limited English proficiency experience substantial barriers to communication in the healthcare setting, leading to medical care that is less safe, less efficient, less effective, and inequitable. Professional interpreter use has repeatedly been shown to improve outcomes and reduce disparities, yet it remains widely underused. This study will test two discrete, scalable implementation strategies for improving professional interpreter use in primary care, while collecting detailed information about mechanisms of action and costs that will be applicable to many sites of care and contribute meaningfully to the goal of reducing communication-based disparities. .